2006 Cancer Model Mechanisms

[unreadable] DESCRIPTION (provided by applicant): The unique setting of the Gordon Research Conference (an intimate and highly interactive conference, with a format that is designed to enhance scientific exchange) will make this a unique and powerful forum for discussing and exploring future directions of cancer research. [unreadable] [unreadable] [unreadable] [unreadable]